SUBSTRATE CYCLES, CALORIGENESIS, AND SMOKING CESSATION

Using stable isotope techniques, this protocol is evaluating the metabolic effect of smoking cessation, particularly with respect to its effect on calorigenesis, substrate cycles, and lipid metabolism.